CONGESTIVE CARDIOMYOPATHY

Congestive cardiomyopathy is a form of primary myocardial dysfunction in which patients usually deteriorate progressively, with median survival estimated at 2 years. Its pathogenesis may be immune-mediated. Anecdotal series suggest that antiinflammatory therapy may be beneficial. The role of endomyocardial biopsy in management of congestive cardiomyopathy remains controversial. The Congestive Cardiomyopathy Protocol is a prospective randomized study of anti-inflammatory therapy with Prednisone and, in some cases, Cyclophosphamide. Initial evaluation of each patient includes extensive invasive and noninvasive cardiac test, including endomyocardial biopsy. After pathological stratification, patients are assigned randomly to an antiinflammatory treatment group or to a control group. Detailed cardiovascular re-evaluations are conducted periodically from 3 months to 2 1/2 years. Concomitant with the assessment of efficacy of antiinflammatory therapy, questions being scrutinized include: (1) whether quantitative histologic and immunologic analysis of endomyocardial biopsy specimens will provide prognostic indication, (2) the natural history, (3) the incidence of cardiac inflammation in congestive cardiomyopathy, and (4) the utility of hemodynamic measurements, e.g., echocardiography, gated blood pool scanning, and other techniques in management and prognostic assessment of patients with congestive cardiomyopathy. This study represents the only randomized prospective trial evaluating the role of anti- inflammatory therapy in patients with inflammatory dilated cardiomyopathy. The study has now entered all intended patients. Follow-up and data are in progress.